Exercise and muscle mitochondria in Alzheimer's Disease

PROJECT SUMMARY
During the early stages of Alzheimer’s Disease (AD), skeletal muscle mass and function precipitously declines
in comparison to those who are cognitively intact, potentially due to poor mitochondrial health in skeletal muscle.
Thus, bioenergetics of peripheral tissues, and skeletal muscle in particular, may have an underappreciated role
in AD etiology. Exercise is an effective means to promote mitochondrial, as well as, skeletal muscle health.
However, whether regular exercise has therapeutic potential for delaying or preventing AD is an outstanding
question. We present evidence of impaired skeletal muscle AMPK-signaling response to exercise in 5xFAD mice,
a model of AD. We show in 5xFAD mice that muscle dysfunction is present at a young age before observable
cognitive decline and that muscle loss and impaired mitochondrial health manifest along by an age associated
with cognitive decline. We present evidence that mitochondrial respiration does not improve following 12 weeks
exercise training in 22-week-old 5xFAD mice compared to WT littermates. In sum, bioenergetic dysfunction in
muscle may underlie a maladaptive response to exercise prior to overt manifestation of AD-related pathology.
There is a critical need therefore to define the adaptive mechanisms in muscle in relation to neurophysiological
changes over the continuum of AD pathology to identify novel therapeutic targets. Our central hypothesis is that
impaired bioenergetics precedes manifestation of overt AD neuropathology resulting in maladaptation in muscle
to exercise training. To test our hypothesis, we propose two aims: Aim 1) Determine the adaptive response of
muscle mitochondria to endurance exercise training in AD mice before development of AD. We will assess
mitochondrial respiration and reactive oxygen species (ROS production in intact muscle fibers and as well as
synthesis (i.e. biogenesis) and breakdown (via D2O labeling - GC/MS) of muscle mitochondria in 22-week-old
5xFAD and APP/PS1 male and female mice following 12 weeks voluntary wheel running (exercise training) (1a),
determine pre- and post-exercise training muscle function in vivo (Aurora), neuromuscular junction integrity
(histochemistry) and mitochondrial quality (confocal microscopy) in novel MitoTimer/5xFAD transgenic mice (1b),
assess central (hippocampus) and peripheral (plasma NfL) neuropathology (1c), and perform untargeted
metabolomics of muscle and hippocampus following exercise training (1d). Aim 2) Determine the tissue-specific
and functional roles for AMPK⍺1 in AD etiology in 5xFAD mice. We will assess mitochondrial function,
proteostasis, development of neuropathology, and metabolomics in both muscle and hippocampus at 3, 6, and
9 months of age in muscle- and motor neuron-specific AMPK⍺1 knock-out mice, as well as novel gain- and loss-
of-function AMPK⍺1(T172A) knock-in mice. Our findings will elucidate the maladaptive response of skeletal
muscle mitochondria to exercise training in context with AD neuropathology and the integrated isoform-specific
functional role of AMPK⍺ in AD etiology. These studies will provide mechanistic to the integrated pathology along
the continuum of AD pathology between skeletal muscle and brain and the role of exercise as a therapeutic.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will advance mechanistic understanding of exercise adaptation in skeletal muscle of a relevant AD mouse model and the roles of a key regulator of cellular energetics in AD etiology, a pathology for which there are few treatment options. The project is relevant to NIA’s mission because it focuses on the molecular and physiological response of skeletal muscle mitochondria in the context of AD neuropathology that indicates a maladaptive bioenergetic response to exercise, which may elucidate an integrated mechanism that will take into account the system-dependent nuance of bioenergetic dysregulation in AD etiology.